Placenta-specific maternal plasma proteomic biomarkers of fetal death

Tarca, A.L., 2022
The fetal mortality rate in the USA is 5.73 per 1,000 births, and there are significant disparities
among racial and ethnic groups. While factors such as complications of the placenta, umbilical
cord, congenital anomalies, and maternal conditions may be involved, one-third of fetal deaths are
classified as unexplained. Our preliminary data suggest that novel placenta-specific proteins offer
more discriminating power for fetal death cases compared to current maternal plasma biomarkers.
However, the question of whether detection of such protein dysregulation in samples collected
earlier in gestation from asymptomatic patients will improve prediction of fetal death compared to
known biomarkers remains to be answered. The studies proposed in this R21 application are
important because reliable identification of women at risk for fetal death is needed to enable use of
preventive strategies such as pravastatin, a drug that prevents recurrent fetal death and placenta
and maternal vascular diseases. Therefore, we will profile most promising maternal plasma protein
candidates in samples collected weeks before fetal death diagnosis and in gestational age-
matched controls. Samples were identified in the Wayne State University Perinatal Biobank. Using
machine learning and predictive analytics pipelines as we have previously described, we will
generate a placenta-specific plasma protein signature that is predictive of fetal death in
asymptomatic patients. Multi-protein machine learning models, such as elastic net and random
forest, will be developed and tested using cross-validation to ensure generalizability. Furthermore,
we will assess the specificity of the fetal death proteomic model in an independent existing
longitudinal dataset that includes data from normal pregnancies and cases of preeclampsia and
small-for-gestational-age neonates. Finally, we will explore the molecular subclassification of fetal
death cases using clustering algorithms based on plasma protein dysregulation prior to fetal death.
The goal of such analysis is to generate additional hypotheses and tackle the heterogeneity of the
fetal death phenotype, which has historically hindered the identification and validation of
biomarkers for this syndrome.

Public health relevance
Tarca, A.L., 2022 Prevention of fetal death requires non-invasive and affordable biomarkers to identify patients at risk early in pregnancy. Our preliminary large-scale proteomics data collected at the time of diagnosis of fetal death suggests that novel maternal plasma proteins can improve discrimination relative to state-of-the-art biomarkers, however, it is not known if such protein dysregulation is present several weeks prior to the diagnosis. This study will profile placenta-specific proteins in samples available from a large set of patients who experienced fetal death and gestational age- matched controls to generate machine learning predictive models of fetal death and identify possible molecular subtypes of fetal death.